The Acquisition of a Zeiss Flourance Phase Contrast Inverted Microscope

The University of the District of Columbia is requesting the acquisition of a Zeiss AX10 Observer
7 Inverted LED Fluorescent Motorized Microscope which is set-up for Brightfield that allows for
Fluorescence studies with new fluorescence filter Sets Dapi/Fits/Texas Red. This instrumentation
will be an excellent addition for several biology faculty who are conducting biomedical research
with several diverse objectives. This will encourage students to take advantage of the opportunity
to gain experience and use highly sophisticated equipment and novel research techniques. The use
of this microscope for novel classroom assignments will add considerably to the comprehension
of biological phenomena. This excellent teaching tool will be used for a variety of courses and will
give the students knowledge of how the concept of fluorescence is used in biomedical research. It
is projected that at least 48 to 50 students can make use of this instrument during a semester. It is
excellent for use in biological studies by enhancing several components. There are six-positions
Motorized Filter Cube Turret DAPI - EX 375/28nm DM 415nm EM 460/50nm (NEW FILTER
SET), FITC - EX 480/35nm DM 505nm EM 535/40nm.
This microscope has features that elevates it above several instruments that are used to detect
fluorescence and as a tool for immunocytochemistry. It should also be noted that the selection of this
microscope was done with much concentration on the details of its salient features, and I cite that
most of these features have elevated this superb microscope above any other instrument of
comparable price ranges on the market today. For example, (1) lumencor SOLA white light LED
fluorescent light source (excitation range of 380nm to 660nm); (2) observer 7 brand is the newest,
current, and exclusive offering from Zeiss, thus, this microscope is top of the line in its
technological offerings; (3) new Filter Cubes for DAPI, FITC, and Texas Red dyes.
We will procure a colleague, Dr. Jan Blancato, Professor, Georgetown University, who has a great
deal of experience in the use, care and upkeep of a fluorescent microscope to lead an advisory
committee that will function in the maintenance of this instrument and use the “Piece of Mind”
concept designed by Zeiss for the most efficient use and upkeep of the microscope. Additionally,
we will have the microscope assembled by a representative from Zeiss using the most efficient and
comprehensive methods to convey the importance and necessity of the upkeep of this fine piece
of equipment.

Public health relevance
Narra�ve for Instrumenta�on Grant The Zeiss AXIO Observer 7 Inverted LED Phase Contrast Fluorescence Microscope will give Faculty and Students at the University of the District of Columbia an opportunity to conduct research using a biomedical tool that can localize or detect in situ, molecules, point measurements and �ssue including changes in these areas that may have major eﬀects on the cell and its surrounding environment. This occurrence plays a major role on public health both locally and na�onally, for the general popula�on in that it is the beginning a pool of diverse health professionals.